Seeds to STEM: Cultivating early Nutrition, Literacy, Numeracy, and STEM knowledge and skills in Teachers, 3-5 year olds, and Families through a Bilingual Asset-based curriculum in Two Major Cities

Seeds to STEM (S2S) proposes a bilingual program that educates urban children ages 3- 5,
their families, and preschool teachers about the importance of childhood nutrition, early
STEM and literacy, and kindergarten readiness in order to address national needs to diversify
the STEM education pipeline and reduce disproportionate rates of poverty, hunger, ill health,
and low educational achievement among families living in dense cityscapes. This SEPA
project has an innovative focus on food access and families enrolled in under-accredited early
learning centers, including home-based childcare.
These low-cost options, often chosen by families who work but cannot afford or do not have
access to high quality early childhood learning and care resources, need to be better
incorporated into preschool education improvement initiatives.
We hypothesize that a research- and asset-based approach to simultaneously educating
preschool children, their teachers, and families will promote early STEM and literacy
learning, encourage healthy eating habits, and increase kindergarten readiness among low
income families living in two major cities -- Philadelphia, PA, and Los Angeles, CA. Three
product deliverables will be nationally distributed by the end of a SEPA grant period via a
project website and PI connections to professional networks. In addition to project
participants, nine museums have appended Support Letters to this application.
1 A bilingual inquiry-based curriculum about early childhood nutrition and school
readiness that integrates STEM, literacy, and numeracy learning through
experimental activities growing food inside classrooms, urban gardens, and
family homes;
2 Professional development and in-class coaching for under-accredited pre-K
educators including, as an innovation, home-based childcareproviders;
3 Programs that empower families to learn together, understand kindergarten
readiness, and be more connected to nutrition resources in their communities.

Public health relevance
Seeds to STEM proposes a bilingual culturally appropriate program that educates low- income Black and Latino children ages 3-5, their families, and preschool teachers about childhood nutrition, early STEM and literacy, and kindergarten readiness. It has an innovative focus on food access and serves populations in under-accredited early childhood care and learning centers, including home-based childcare providers. Seeds to STEM will be piloted in two major cities (Philadelphia, PA and Los Angeles, CA) and its three product deliverables will be distributed nationwide via a website and multiple professional dissemination networks.